Promoting health by understanding risk and protective factors for substance use among Latino youth in rural and small town communities in the United States

Abstract
The demographic composition of small towns and rural communities in the U.S. has changed dramatically, in
part because of the large in-migration of Latino families. For communities to support the health of their
members, they must be able to reinforce factors that promote positive youth development (protective factors)
and abate factors that hinder it (risk factors). However, much of what is known about risk and resilience comes
from research on urban communities. There has been little longitudinal research on Latinos growing up in the
rural U.S., and none with sufficient data to understand the etiology of substance use (SU), patterns of health
disparities in SU, and factors influencing their health and wellbeing as young adults. We know little about the
intersectionality of Latino ethnicity, immigrant status, and rural context and how these relate to the
developmental mechanisms of health disparities. This knowledge gap limits prevention and intervention
services, as the prevention science paradigm depends on accurately identifying risk and protective factors
(RPFs) and developing prevention programs targeting these factors to reduce problem behaviors. The present
application capitalizes on existing rich longitudinal data spanning childhood through early adulthood to examine
influences on health and well-being of rural Latino youth. Using this existing data, we will examine health
disparities in substance use and associated RPFs (a) between 3rd-generation rural Latino and non-Latino
White youth, and (b) among rural Latino youth who are 1st-, 2nd- or 3rd-generation immigrants (i.e., children of
immigrant or U.S.-born parents). In the supplemental analyses used for triangulation and validation, we will use
national cross-sectional data and examine differences in the association between RPFs and alcohol, tobacco,
marijuana, and other drug use for Latino youth by the type of residence (rural vs. small and large metro areas)
at the historical time points and age ranges corresponding to the longitudinal study. Findings will provide
rigorous scientific evidence regarding risk and protective processes for Latino youth in rural areas of the U.S.
that may lead to prevention efforts to reduce health disparities in substance use and other health risk behaviors
in young adulthood, and potentially reduce disparities in serious illness later in the life course.

Public health relevance
PUBLIC HEALTH RELEVANCE This study aims to examine health disparities in substance use and factors influencing the health and well- being of Latino youth residing in rural and small-town communities of the United States, a growing but understudied and underserved population. Findings from the proposed project will provide much needed empirical evidence about risk and protective processes in the etiology of substance use among Latino youth in rural areas of the U.S., and inform the planning, selection, and implementation of prevention programs that will reduce health disparities and improve the health and well-being of vulnerable populations.